Calorie Restriction, Body Temperature and Alzheimers Disease

Calorie restriction (CR) has anti-aging effects, prolongs lifespan and reduces the incidence of age associated
diseases. Experimental evidence in animal models indicates that CR ameliorates the neuropathologic and
behavioral abnormalities seen in transgenic models of Alzheimer’s disease (AD). Our previous work
demonstrated that one mechanism by which CR promotes longevity is by reducing core body-temperature (Tb).
Since virtually all proteins are sensitive to heat denaturation, nature has created cellular systems to protect cells
from even small quantities of abnormally folded toxic proteins as far back in evolution as bacteria. We now
hypothesize that the beneficial effects that CR has on the AD models are at least in part due to its ability to
reduce Tb and the subsequent proteotoxic stress. Here we propose experiments to test our hypothesis regarding
the role of lowering body temperature as being a major factor in both life extension and the salutary effect of CR
in the well validated Tg2576 transgenic model of human AD.

Public health relevance
Calorie restriction is beneficial in experimental models of Alzheimer’s disease. We propose experiments to determine to which extent these beneficial effects are due to the hypothermic response that occurs during calorie restriction.